Mechanisms of inflammatory osteoblastogenesis and bone formation

The integrity of the adult skeleton is maintained by balanced remodeling between osteoclast-mediated
bone resorption and osteoblast/osteocyte-mediated bone formation. However, excessive bone loss but limited
bone formation often occur in many chronic inflammatory settings, such as rheumatoid arthritis (RA) and
periodontitis. In contrast to the extensive studies on osteoclastic bone resorption, the deregulated
osteoblastogenesis and damaged bone formation, especially in inflammatory conditions, are much less
understood. There are no known effective therapies to improve bone formation in RA currently.
We recently identified constitutive type-I Interferon (IFN-I) response activity in osteoblasts, evidenced by
the constitutive expression of type I IFN-stimulated/response genes (ISGs), which is a newly recognized cellular
signature of osteoblasts. It is intriguing that osteoblasts, a non-typical immune cell type, present IFN-I response
signature in the absence of infection. We found that the constitutive IFN-I response plays an inhibitory role in
osteoblast differentiation and bone formation with genetic evidence, which underscores its biological significance
in osteoblastogenesis and bone homeostasis. ISGs are usually the indicators and effectors of IFN-I
pathway/response. Among the ISGs, we identified Eif2ak2 (encoding eukaryotic translation initiation factor 2-
alpha kinase 2) as an important inhibitor of osteogenesis. Importantly, Eif2ak2 is a central regulator of IFN-I
response in osteoblastic inhibition. Eif2ak2-/- mice exhibit significantly high bone mass with prominently increased
osteoblastic bone formation in vivo. Our data including RNAseq results further reveal a novel pathway mediated
by IFN-I-Eif2ak2-β-catenin in the regulation of osteoblastogenesis. Moreover, inflammatory cytokine TNFα
significantly enhances the constitutive IFN-I response in osteoblasts, indicating a novel molecular mechanism by
which TNFα restrains bone formation. We also found a drastic aging effect of the constitutive IFN-I response on
bone mass.
Based on our preliminary results, in this application, we will further 1) investigate the mechanisms by
which the constitutive IFN-I response suppresses osteoblastogenesis; 2) investigate how the effects of
constitutive IFN-I response in osteoblasts/osteocytes on bone homeostasis are influenced by aging in both males
and females; and 3) investigate the functional importance of constitutive IFN-I response in osteoblasts/osteocytes
in inflammatory arthritic animal models with osteogenic defects.
Successful completion of this proposal will shift the currently established paradigm in immunology for
IFN-I response to a new paradigm in bone with distinct function and mechanisms. Identification of previously
unrecognized mechanisms in osteogenic inhibition will provide a rational framework for developing new
therapeutic approaches to enhancing osteoblast/osteocyte-mediated bone formation/repair in skeletal diseases.

Public health relevance
Project Narrative Bone destruction is a severe consequence of many skeletal diseases, such as rheumatoid arthritis and periodontitis. This application will explore underlying mechanisms and provide new attractive therapeutic approaches for suppressing bone destruction and improving new bone formation and repair.